A Systems Pharmacology approach to predict the effects of pregnancy and infectious diseases on transporter-mediated drug disposition

SUMMARY
Pregnancy and inflammation (due to infectious diseases) are each known to alter drug pharmacokinetics (PK) by
changing the expression and activity of transporters and/or drug-metabolizing enzymes (e.g. CYPs). Quantifying
changes in drug PK caused by pregnancy and/or cytokines (elevated during inflammation) is important for
rational design of dosing regimens of drugs for pregnant women with infectious diseases. While changes in the
PK of CYP-cleared drugs by pregnancy and cytokines have been well-delineated using CYP probe drugs, such
data are sorely missing for transporters. However, obtaining data of changes in drug PK by pregnancy and/or
pro-inflammatory infectious diseases for every possible transported drug administered to pregnant women (with
or without infection) is logistically impossible. Therefore, alternative approaches that can generalize across
drugs, transporters and pro-inflammatory infectious diseases are urgently needed. These approaches should
accurately predict the alteration in in vivo activity of transporters by pregnancy and pro-inflammatory cytokines.
In this proposal, we propose a systems pharmacology approach to predict the effects of pregnancy and/or
pro-inflammatory infectious diseases on transporter-mediated drug PK. Our hypothesis is that the
magnitude of change in drug PK by pregnancy and/or cytokines can be predicted through clinical PK studies
using probe drugs and in vitro experimental data as well as Physiologically Based Pharmacokinetic (PBPK)
modeling and simulation (M&S). While probe drugs can yield clinically significant and valuable data, transporter
probe drugs, unlike CYP probe drugs, have the limitations that they are not selective. Therefore, to overcome
this limitation, we propose a two-pronged approach which utilizes both primary human cells (e.g.
hepatocytes, renal epithelial cells, intestinal enterocytes) and transfected cells expressing individual
transporters of interest. Using quantitative targeted proteomics, the human cells will allow us to determine
the effect of pregnancy hormones or cytokines, on the expression of transporters in these cells. The transporter-
transfected cell studies will allow us to determine the intrinsic transport clearance of a drug by a single
transporter per pmol of a transporter. Combined, these data will allow us to predict, through PBPK M&S,
transporter-mediated clearance of drugs in pregnant women with and without infection. These studies will
address a critical gap in our understanding of the effects of pregnancy and/or pro-inflammatory
infectious diseases on transporter-mediated drug disposition. Since our approach can be applied to other
drugs and other inflammatory diseases, its significance goes well beyond the drugs and inflammatory diseases
investigated here. We would like this application to be considered under the NIH-FAPESP initiative (NOT-TW-
16-001). Under this initiative, the clinical PK studies will be conducted in pregnant women with infectious
diseases in Brazil, and the clinical PK data obtained will be used to verify our PBPK model predictions.

Public health relevance
NARRATIVE At present, methods to predict pregnancy-induced and cytokine-induced changes in transporter-mediated drug disposition are not available. We propose a systems pharmacology approach to address this significant knowledge gap. Such studies are important for rational design of dosing regimens of drugs that maximize efficacy and safety when administered to pregnant women with pro-inflammatory infectious diseases.